Gamma herpesvirus impact on required B cell:CD4 T interactions in a B cell-dependent, antibody-independent mouse model of multiple sclerosis

PROJECT ABSTRACT
Potential for Epstein-Barr virus (EBV) involvement in multiple sclerosis (MS) etiology is
increasingly recognized, but how infection could trigger or augment myelin autoreactivity is
unclear. MS is an immune-mediated demyelinating disease of the central nervous system
(CNS), and despite first line drugs that limit symptoms, disease remains incurable. Due to its
early life onset and rise in prevalence for nearly 1 million Americans, MS imparts an immense
health and economic burden on the United States. Adaptive immune cells, particularly CD4 T
cells (CD4s), have long been considered integral players in neuroinflammation and
demyelination in MS, and B cells have been appreciated as playing a pathobiological role,
highlighted by the success of anti-CD20 B cell depletion therapy (BCDT). Mechanistically, B
cells are thought to support autoreactive CD4s through antigen presentation. Given EBV is a
gamma herpesvirus (gHV) that latently infects human B cells, it is postulated infection may
influence disease-driving B:CD4 interactions by enhancing autoantigen presentation. Few MS
animal models are well-equipped to dissect B:CD4 interactions in this viral context, as the vast
majority of EAE (experimental autoimmune encephalomyelitis) studies feature B cell-
independent disease. To circumvent this, we have developed a B cell-dependent, antibody-
independent EAE model in WT B6 mice featuring CD4 T cell immunoreactivity to the
extracellular domain sequences of the highly abundant and 100% conserved myelin proteolipid
protein (PLPECD). Through rigorous experimentation, we have identified B cell-mediated antigen
presentation to CD4s through MHC class II as the required pathogenic B cell mechanism in
PLPECD-induced EAE, where B cells engage PLPECD through the B cell receptor and are more
efficient than dendritic cells at processing and presenting immunodominant residues from within
PLPECD to PLP178-191-reactive CD4 T cells. Further mimicking the sustained pathogenic B cell
involvement seen in MS and unlike B cell-independent EAE driven by PLP178-191, BCDT robustly
ameliorates established PLPECD disease. Thus, we have developed a novel and powerful tool to
investigate how gHV infection impacts key pathogenic B:CD4 interactions during development
of autoimmune demyelinating disease. We hypothesize that gHV infection of WT B6 mice
exacerbates B cell-dependent but not B cell-independent EAE by enhancing B cells’ support of
autoreactive CD4s. Specific Aim 1 will determine how gHV infection affects B cells’ support of
disease-driving CD4 T cells. Specific Aim 2 will determine how gHV infection impacts B cell-
dependent vs. B cell-independent EAE.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis (MS) is an incurable immune-mediated demyelinating disease of the central nervous system that affects nearly 1 million Americans. B cell depletion therapy success and the enigma of the B cell-tropic Epstein-Barr virus’s role in MS has invigorated intense interest in how viral infection and B cells contribute to disease. We will use our novel B cell-dependent, antibody-independent EAE model to gain fruitful insight into how an EBV-related murine gamma herpesvirus impacts pathogenic B cell:CD4 T cell interactions in developing disease.